MEOX2: A Critical Regulator of Alveolar Fibroblast Function

ABSTRACT:
An in-depth understanding of the mechanisms that regulate alveolar septation and septal wall maturation will be re-
quired to develop therapies for premature infants with Bronchopulmonary Dysplasia (BPD). We and others have begun
to define changes in PDGFRa myo, lipo and matrix fibroblast (FB) function during alveolarization,
homeostasis, regenera-
tion, and fibrosis. Our long-term goal is elucidation of molecular regulators of FB functions and how diverse FBs support
the alveolar niche. Our objective herein is to identify molecular mechanisms that result in functional changes in alveolar
matrix FBs that regulate extra cellular matrix (ECM) organization and capillary network formation. Integration of tran-
scriptomic datasets identified MEOX2 as a transcription factor of non-contractile fetal and postnatal alveolar FBs. Our
preliminary data show that conditional inactivation of Meox2 in perinatal alveolar matrix FBs resulted in alveolar simpli-
fication, gain of contractile FB function, and thickened interstitial ECM, comparable to findings in BPD and animal models
of hyperoxia. Meox2 inactivation in alveolar matrix FBs also resulted in impaired capillary endothelial network for-
mation, demonstrating a thus far unidentified role of alveolar FBs in postnatal angiogenesis. Inactivation of Meox2 re-
sulted in an increase of ductal myo FB differentiation and gene expression analyses predict aberrant matrix synthesizing
function in matrix FBs that is associated with abnormal vascular development and cell migration. The central hypothesis
is that Meox2 directly regulates genes for matrix and myo FB function and their subsequent capacity to support vascular
capillary formation. The rationale for this research is a new understanding of the regulation of matrix FB function and
how these functionally different FB stages modify ECM and the FB-endothelial crosstalk. Aim 1 will test the hypothesis
that MEOX2 regulates differentiation of myo and matrix FBs from a common mesenchymal progenitor. Using a new
Meox2CreERT transgenic mouse we will identify lineage relationships and activation stages of alveolar FBs during normal
and hyperoxia impaired alveolarization and identify direct MEOX2 target genes that regulate FB function. Aim 2 will test
the hypothesis that MEOX2 regulates ECM composition, which is important for vascular network formation. We will gen-
erate in vitro cell derived ECM from control and Meox2 deficient FBs and determine ECM composition, topography, and
support of angiogenesis. Aim 3 will test the hypothesis that increased CXCL14 signaling from Meox2 deficient FBs to its
receptor CXCR4 on capillary endothelial cells impairs postnatal capillary development. We will use in vivo and in vitro
gain and loss of function analysis to determine the role of paracrine signaling from FBs to endothelial cells that direct
angiogenesis. The proposed research is conceptually innovative, because we ask questions
regarding FB plasticity and
lineage specificity and define molecular players of the functional switches. The proposed research is scientifically innova-
tive, because little is known about their
ECM organizing function or
their role in supporting capillary network formation.
This contribution will be significant because it addresses 1) lack of knowledge of the function of the alveolar matrix FB;
2) identifies and validates the transcriptional network around Meox2 that regulates FB function.

Public health relevance
NARRATIVE: This proposed research is relevant to public health because it is expected to identify the mechanism(s) that result in maladaptive lung fibroblast differentiation and extra cellular matrix deposition, which can be found in chronic neonatal lung diseases, such as Bronchopulmonary Dysplasia, and adult-onset fibrotic lung diseases, such as idiopathic pulmonary fibrosis. Development of regenerative therapies, leading to restoration of lung structure and function, in chronic lung diseases will need to be guided by insights into the mechanistic underpinnings of defective alveolarization. The proposed research is relevant to the part of NIH’s mission pertaining to developing fundamental knowledge that will inform the upstream regulation and downstream function of alveolar matrix fibroblasts with the ultimate objective to restore a microenvironment that is permissive for alveolar repair and allow for proper microvascular network formation.